HIV and Substance Use Cohort Coordinating Center for Emerging and High Impact Scientific Cross Cohort Studies: HIV SUCCESS

The purpose of the HIV and Substance Use Cohort Coordinating Center for Emerging and High Impact
Scientific Cross Cohort Studies: HIV SUCCESS is to support National Institute on Drug Abuse funded cohorts
as they implement research strategies to better understand and address substance use and its consequences
among people with HIV (PWH). Substance use prevalence among PWH is high, and substance use patterns,
including increasing concurrent methamphetamine/opioid use as part of the 4th wave of the opioid epidemic,
continue to evolve. Substantial challenges remain to improve understanding and implementation of
interventions to address substance use and its impacts among PWH. Addressing these challenges is the
overarching purpose of the cohorts and requires a coordinating center (CC) experienced in data integration
and harmonization, health informatics, multi-site coordination, clinical care and intervention experience, and
HIV and substance use research to support the cohorts and comprehensively integrate cross-cohort data. The
resulting resource of comprehensively integrated data will give researchers the potential to address important
scientific and public health questions that would otherwise not be possible in individual cohorts. We will work
with cohorts to allow complex, careful and complete analyses of outcomes and results across diverse
populations using harmonized data. We will bring in data from other cohorts and studies as needed to ensure
that adequate clinical, biomarker, and/or genetic data are available to address key questions. Careful data
harmonization where appropriate will improve the statistical power to identify areas or sub-groups for research
focus and to understand what interventions are proving successful in the broader context of the whole
population of PWH (as opposed to the target population of a single cohort). This team brings vast experience
with HIV cohort data; data linkage and harmonization; methods development; statistical support including
causal inference from longitudinal observational data; health informatics platform and tool infrastructure and
development including data repositories and tools for efficient and accurate electronically collected patient
reported outcomes and outcomes adjudication; providing overall coordination for large collaborations of
cohorts and studies; a strong background in clinical epidemiology of HIV and substance use; and expertise in
applying this information to clinical care and interventions. We also have a comprehensive mentoring approach
to develop a new generation of HIV and substance use researchers. We will support cohorts to enhance data
collection where appropriate, merge and harmonize data when feasible, and work together to address key
questions on HIV, substance use, and outcomes that cannot be addressed by individual cohorts. By providing
project management, mentorship, and support, as well as developing a robust data repository, and
accomplishing the integration and linkage of data, we will achieve a multi-disciplinary integrated network with
multi-site data with sufficient sizes needed to address substance use and its impacts among PWH.

Public health relevance
Narrative The purpose of the HIV and Substance Use Cohort Coordinating Center for Emerging and High Impact Scientific Cross Cohort Studies: HIV SUCCESS for the HIV/AIDS and Substance Use Cohorts Program is to coordinate and support a collaboration of longitudinal cohorts to address emerging and high priority research in the setting of substance use and HIV. We are well-positioned to provide operational support for cohorts and a platform for harmonizing data to address important research questions as we supply infrastructure and resources matched with innovative methodological approaches, scientific leadership including substance use and HIV research expertise, administrative support for protocol development, implementation and dissemination, development of future HIV and substance use research through mentorship, and most importantly a multi-disciplinary team with expertise in substance use treatment and research, clinical HIV, data integration, substance use intervention implementation, epidemiology, biostatistics, and clinical informatics. As the HIV SUCCESS coordinating center, we will bring our vast experience with cohort collaborations such as CNICS, STTR, ROI, ARCH, and NA-ACCORD and with harmonizing HIV data across cohorts which will allow us to generate new knowledge at the intersection of HIV and substance use to inform future research and clinical care in the US.